Spatial signatures of brain health and vulnerability in aging and Alzheimer's disease

PROJECT SUMMARY / ABSTRACT
For decades, the analysis of Alzheimer’s brain pathology has remained, by and large, unchanged, with the
detection of Aβ plaques and tau tangles representing the hallmarks features of Alzheimer’s disease (AD) that
are intimately linked to cognitive decline. This traditional analysis of AD brain is very qualitative and limited by
the slow and tedious “one-at-a-time” approach to detect individual markers of interest in the brain. This lack of
innovation has posed major limitations in achieving more rapid, comprehensive, and quantitative views of
dementia. Recently, a technology was developed called cytometry time-of-flight (CyTOF) imaging mass
cytometry (IMC) and its potential for translational applications, especially neurodegenerative diseases, is
remarkable. The reason for this is that we can now analyze all cell types and structures in a single
experimental design. We can also quantify and mine these data to provide spatial insights into how the brain
degenerates over time to establish a “brain signature” of aging and dementia. Such multiplexed analysis of a
large panel of human brain samples will provide rapid quantitative insights that will inform our understanding of
AD pathophysiology. In this study, we developed a “brain vulnerability and resilience” panel suitable for probing
mouse and human brains, with particular emphasis on immune factors that have been implicated in AD. By
probing their abundance, cell-type specific accumulation, and spatial proximity in relation to plaques and
tangles, we will provide global insight into AD progression. We hypothesize that the ensemble of spatial
information, gleaned from 45+ simultaneous markers of interest, will point to specific microglia subpopulations
that drive or suppress brain pathology. In Aim 1, we will generate a comprehensive brain signature of aging
and AD by employing IMC on a panel of human brains to derive in situ spatial information of brain health and
resilience, providing a thorough assessment of disease trajectories. The inclusion of normal aged brains will
also allow us to delineate the earliest stages of age-related brain changes, a timeframe that is more amenable
to eventual therapeutic interventions. We will then validate the emergence of these spatial signatures using
well characterized AD mouse models that show either slow- or fast-progression towards cognitive decline. In
Aim 2, we will develop an automated bioinformatics approach for multi-sample IMC data to segment brain cell
types and define their cellular microenvironments. We will also develop machine learning approaches to
summarize the spatial patterns and predict clinical outcomes. This proposal is a highly innovative merging of
unique experimental and computational strengths; it is significant since it represents a conceptual leap in how
we image, visualize, and quantify brain data; and it has enormous clinical implications, since it could highlight
multiplexed imaging coupled with predictive modeling to determine which patients transition from the normal to
diseased state. Given that immune mediators often circulate peripherally, our study provides a foundation for
the use of IMC to discover future biomarkers as readouts for immune dysfunction.

Public health relevance
PROJECT NARRATIVE Traditional postmortem imaging of the brain continues to be very qualitative and is limited by the slow “one-at- a-time” approach. Using imaging mass cytometry (IMC), a recently developed quantitative multiplexed approach to image > 45 markers of interest, we will define the spatial signatures of the aged and Alzheimer’s (AD) brain, with particular emphasis on deriving information on microglia function and activity, in space and over time. By also developing the bioinformatics pipelines needed to evaluate brain microenvironments, our study could translate clinically towards better diagnostic and predictive capabilities for patients with dementia.